Community Outreach Program

The National Community Outreach Program will focus efforts to reduce the burden of cancer and other comorbidities that affect the American Indian and Alaska Native population by maintaining and expanding our network of community and national partnerships dedicated to developing effective community driven strategies to improve cancer control.